Investigating the logic of homeostatic sleep control circuitry in Drosophila

Abstract
Continuous sleep loss degrades the physiology of systems throughout the brain and body, eventually causing
death. To prevent these consequences, homeostatic mechanisms activate after prolonged waking to promote
sleep. Understanding neural mechanisms that control sleep homeostasis will provide insight into the basic
functions of sleep and aid the development of interventions that provide resilience to sleep loss, but these
circuits have not been clearly characterized. Previous studies have identified a small population of fly neurons
that project into the dorsal Fan-shaped Body (dFB) and act as a homeostatic control center for sleep. We have
conducted an RNAi screen to identify sleep-promoting dFB input signals and have characterized an output
signal released by dFB neurons to induce sleep. In this proposal, we will: (1) use electrophysiology along with
receptor RNAis and mutants to confirm dFB input signal identity, (2) create genetic reporters for post-synaptic
targets of dFB neurons, and (3) use patch-clamp recordings to test whether dFB excitability is elevated to
promote sleep during memory consolidation and degraded in aged flies, resulting in sleep fragmentation.

Public health relevance
Public health relevance statement Consequences of insufficient sleep range from acute cognitive deficits to increased risk of chronic illnesses such as diabetes and hypertension. The proposed project will use a simple model system to understand how sleep control centers detect when the organism requires sleep, then activate to promote sleep. The proposed research is expected to improve our understanding of how sleep is regulated and identify new sleep-promoting interventions.